Training in Clinical and Basic Neuroscience

Abstract
Centered in the Departments of Neurology and Neurosurgery at the University of Michigan Medical School, this
longstanding training program in Translational Neuroscience includes additional stakeholders across the
University. The program’s preceptors train basic scientists and clinician-scientists to conduct research in
neurological diseases across the translational continuum, from basic mechanistic work through preclinical and
clinical research. While mentored research under the direction of established investigators is the central pillar
of this program, a new “mentoring the mentor” initiative will support promising younger preceptors with
guidance from a paired senior investigator. In addition, a new mentor training program will be instituted, as
designed by the NIH-funded National Research Mentoring Network, that will benefit junior and senior mentors
alike. Our trainees’ mentored research experiences are complemented by appropriate formal education and a
Core Program designed to provide rigorous quantitative and biostatistical training, expand the trainees’
knowledge beyond their narrower research focus, and ensure successful career progression. One of the
strengths of this program is its integration of clinical and basic science training: laboratory scientists are
exposed to clinical issues via their colleagues and mentors in the program, and clinical researchers gain a
better understanding of the mechanisms of disease via their basic science exposures. Laboratory-based
research training follows a project-oriented approach, with careful mentoring by the preceptors. Trainees in
clinical science programs are able to complete a Master’s Degree, such as the School of Public Health’s
Master’s Program in Clinical Research, but a formal degree is not required of all participants. Trainees include
both biomedical PhD scientists who seek training in disease-oriented neuroscience, and clinicians – principally
neurologists and neurosurgeons - who have completed clinical training and have chosen to pursue a
laboratory-based or clinical research career. They are selected competitively by the program’s Executive
Council. The recruitment process includes a strong diversity outreach initiative connected by a bridging
program to NINDS-sponsored programs aimed at increasing diversity in Neuroscience graduate and
postgraduate student education. This training program is embedded within the University’s rich research
environment which includes a highly collegial and interdisciplinary neuroscience research community, excellent
core resources for biomedical research, and strong resources for translational and clinical research. Our prior
trainees have been very successful in moving on to and establishing productive careers in neuroscience, and
we are forced to turn away excellent applicants every year. We propose to continue our trainee number at five
postdoctoral fellows per year, with each trainee in the program for 1-2 years depending on their success in
obtaining external funding.

Public health relevance
Project Narrative This program prepares a diverse group of junior investigators for research careers across the translational continuum of neuroscience. We offer training experiences designed to educate basic scientists about neurologic disease and to provide clinician-scientists pursuing laboratory-based research or clinical research the opportunity to develop and enhance their research skills. Training is a combination of mentored research, formal education, and a Core Program focused on enhancing specific research, quantitative, biostatistical and career development skills.